Tryptophan-derived oncometabolites as novel mediators of cancer immune evasion

PROJECT SUMMARY
Liver cancer incidence is rising globally, with an overall survival rate of about 20%. Developing new therapeutic
strategies is therefore critical to improve treatment response and increase survival. Our lab has identified a
novel metabolic vulnerability in liver cancer which could pave the way for new mechanisms of therapy. Starving
tumors of the essential amino acid tryptophan (Trp) completely abrogates liver cancer growth in genetically
engineered mouse models as well as syngeneic xenografts. Importantly, the vast majority of bodily Trp is
metabolized and not used for protein synthesis. Therefore, we broadly tested adding back various Trp
metabolites to identify those that were critical for tumor growth. We discovered that the novel oncometabolite
indole-3-pyruvate (I3P) is the only downstream product of Trp capable of rescuing liver cancer growth.
However, the growth-promoting effects of I3P are significantly stronger in vivo than in vitro, suggesting that it
has a non cell-autonomous mechanism of action. I surveyed multiple different immune cell types relevant to
the liver cancer microenvironment and found that I3P may play a critical role in modulating macrophage
polarization. My studies will therefore focus on defining the role of I3P-mediated macrophage phenotypes in
the immune response to liver cancer.

Public health relevance
Project Narrative Compared to normal cells, cancer cells have a greater need for nutrients to fuel cell growth because of their unchecked proliferation. We found that liver cancer cells require large amounts of the essential amino acid tryptophan to generate the oncometabolite I3P. Here, we seek to determine the importance of I3P in inhibiting cancer cell clearance by the immune system.